Chromatin PTEN: Its Regulation And Functions

Chromatin PTEN: Its Regulation And Function
Phosphatase and tensin homolog (PTEN) functions as a major negative regulator of the PI3K signaling
pathway. PTEN is frequently mutated in a variety of human malignancies including glioblastoma, prostate
cancer, and breast cancer. Inherited PTEN mutations cause cancer-susceptibility conditions. PTEN is also
known to have nuclear/chromatin functions, deregulation of which apparently causes chromosomal instability.
However, the exact functions of chromatin PTEN and its molecular regulation remain poorly understood. Past
research shows that proper subcellular localization of PTEN after genotoxic stress is regulated by molecular
mechanisms that involve post-translational modifications. We recently demonstrated that chromatin PTEN
significantly increases during mitosis, coinciding with an increase in PTEN phosphorylation in the C-terminal
tail. Biochemical and molecular analyses revealed that Plk1 was responsible for PTEN phosphorylation on
S380, a residue not targeted by any other known kinases. We and others have shown that PTEN specifically
interacts with Cdh1 (APC/CCdh1) and WWP2, two ubiquitin E3 ligases. Chromatin PTEN removal during mitotic
exit and the physical interaction between PTEN and Cdh1 was a proteasome-dependnent process.
Furthermore, we observed that a cleaved form of WWP2 specifically is enriched during G2 and mitotic stages,
correlating with chromatin PTEN accumulation. WWP2 silencing accelerates mitotic progression. We
hypothesize that chromatin PTEN plays a crucial role in mitotic progression, whose subcellular
localization and function are controlled by Plk1, Cdh1 and WWP2, and that its molecular deregulation
leads to chromosomal instability and tumor development. To test the validity of our hypothesis, we will
determine whether and how phosphorylation facilitates chromatin translocation of PTEN, dissect the role of
PTEN ubiquitin E3 ligases in regulating its stability, and study the phosphatase-independent function of PTEN
in supressing chromosomal instability and tumor development using both in vivo and in vitro models. Our
proposed studies will not only elucidate the molecular mechanism by which chromatin PTEN is regulated
during the cell cycle, but will also reveal how PTEN functions in maintaining chromosomal stability and
suppressing malignant transformation. This line of research can lead to the identification of new molecular
targets in the PTEN regulatory network that can be explored for cancer drug designs and development.

Public health relevance
NARRATIVE PTEN is a key negative regulator of cell proliferation that primarily functions to inhibit the PI3K/Akt signaling axis and guards against chromosomal instability during cell division. This proposal plans to elucidate the molecular mechanism by which chromatin PTEN functions in mitosis, as well as understand how chromatin PTEN is regulated during cell division. These studies are of great significance for our understanding of how normal cells suppress chromosomal instability, aneuploidy, and tumorigenesis.